Modeling of acute kidney injury in organoids.

Of patients admitted to VA intensive care units, nearly one quarter have or develop acute kidney injury (AKI),
which is associated with an approximately five-fold increase in mortality. AKI survivors can develop end-stage
renal disease, subsequently requiring dialysis or transplantation to survive. Patients in the Veteran population
are diagnosed with AKI at a rate that is higher than that of the civilian population. Current AKI modeling is
largely in animal models and dissociated human tubule cells. Animal models have species-specific challenges
and human proximal tubule cells grown in 2D on hard plastic surfaces readily lose their epithelial
characteristics. Both of these models have advanced our understanding of AKI, which is difficult to study in
human patients due to lack of biopsy tissue samples. Despite years of study in these traditional models of AKI,
the clinical situation for Veterans has not changed, as we still rely on supportive care for AKI treatment. Human
kidney organoid in vitro modeling is a robust and highly innovative approach with numerous advantages. First,
the amount of drug that is needed to perform tests in the human kidney organoid model is substantially lower
than in mouse models. Secondly, species matching of model and drug is an important issue in many areas of
medicine including gene and cell therapy. Finally, testing of therapeutics in human kidney organoid models of
kidney injury first would reduce animal usage and ensure that animal use is well-justified. Validation of
advanced human kidney organoid reporter models is necessary to further demonstrate to the research
community the potential of human kidney organoids. Our lab and others have shown that human kidney
organoids treated with cisplatin have consistent upregulation of kidney injury molecule 1 (KIM-1, also known as
hepatitis A virus cellular receptor 1 or HAVCR1). In this pilot award, we will edit the genome of a line of human
induced pluripotent stem cells (iPSC) for high-throughput screening of human kidney organoids with live
readout of kidney injury. In Aim 1, iPSC will be gene edited with the same Cas9 guide RNA and homologous
recombination cassette as in our previous study to target reporter genes into the KIM-1 locus. Additionally, we
will edit a marker of proximal tubule cell type specification to control for organoid to organoid and batch
variation. These iPSC-derived kidney organoids will express mTagBFP2 from proximal tubule cells and
upregulate GFP and luciferase in response to injury. All lines generated will be confirmed for iPSC
pluripotency, whole genome sequencing, and functional testing. In Aim 2A, we will fully validate cellular
differentiation in 96-well plates. In Aim 2B, organoids grown in 96-well plates will be tested for dose-dependent
injury response. The equipment for confocal high-throughput fluorescent and luminescent screening is
available through the Vanderbilt High-throughput Screening Facility. At the conclusion of this pilot award, we
will possess a fully characterized and validated reporter cell line for live, quantitative assessment of human AKI
in vitro. This line will enable high-throughput screening of libraries to uncover unknown sources of
nephrotoxicity as well as discover new AKI therapeutics.

Public health relevance
Acute kidney injury affects nearly one quarter of Veterans admitted to VA intensive care units. Acute kidney injury is a major cause of morbidity and mortality in the Veteran population. Veterans who survive are at risk of developing chronic kidney disease or end-stage kidney disease requiring either dialysis or kidney transplantation for survival. Acute kidney injury can be difficult to study in human patients as kidney biopsies obtained from these patients during the normal course of care are rare. Current work on acute kidney injury is largely done in animal models, which has greatly advanced our understanding of the mechanisms. Yet, despite years of work with these expensive and difficult models, the clinical situation for Veterans has not changed as we still rely on supportive care for AKI treatment. We will fully validate next-generation live imaging models of acute kidney injury in human kidney organoids. In the future, performing drug toxicity and mechanistic studies in human kidney organoids first will ensure that animal use is well-justified to reduce animal usage.